Cardiac function and proteomic biomarkers in individuals with perinatal HIV infection or exposure

There are approximately three million individuals with perinatally acquired human immunodeficiency virus
(pnHIV) worldwide and >150,000 new youth with pnHIV (YpnHIV) annually. The incidence of pnHIV has declined
dramatically over the last two decades, yet rates remain high in Eastern and Southern sub-Saharan Africa (SSA)
- threefold greater than the global average. Prior studies from SSA have been unable to resolve whether pnHIV
increases risk of cardiac or physical dysfunction compared to unexposed children or those with perinatal HIV
exposure but who are HIV seronegative (PHEU). Elucidating determinants of cardiac, autonomic and physical
dysfunction in the disproportionately affected population of YpnHIV is critical to identify, treat and prevent cardiac
comorbidities. Comprehensive phenotyping that combines cardiac imaging, physical function assessment,
autonomic dysfunction and molecular profiling represents an innovative approach to fully characterizing the
earliest manifestations of subclinical disease thereby enabling early intervention. Thus, the overall objectives of
this application are to identify imaging and proteomic determinants of cardiac dysfunction in YpnHIV compared
to the HIV unexposed (HU), and to evaluate effects of YpnHIV on physical performance and heart rate variability.
Our central hypothesis is that YpnHIV have worse cardiac and physical function compared to HU and PHEU.
Our hypothesis builds on our preliminary data which identified a high burden of early cardiac dysfunction on
echocardiogram among YpnHIV, and preliminary data linking subclinical cardiac dysfunction among YpnHIV to
proteomic profiles indicating cardiac fibrosis, inflammation, and immune activation from a large HIV care program
in western Kenya. We will test our central hypothesis through the following Specific Aims: (1) Determine if pnHIV
is associated with cardiac dysfunction and abnormal physical performance in children and young adults; (2)
Identify mechanisms of subclinical cardiac dysfunction and related biomarkers in YpnHIV using high-throughput
proteomic profiling; (3) Measure the effect of HIV status on longitudinal change in cardiac and physical function
during a period of rapid adolescent growth. To achieve our Aims, we will conduct a prospective study of a total
of >400 YpnHIV, PHEU and HU in western Kenya who are engaged in a long-term, population-based HIV clinical
care program – the Academic Model Providing Access to Healthcare (AMPATH) Kenya Program. We will perform
echocardiograms, a clinical assessment, six-minute walk testing, heart rate variability assessment and collect
biospecimens for molecular profiling through proteomics. In a sub-sample, we will repeat measures at 24 months
to determine whether YpnHIV, PHEU and HU status impacts progression of cardiac or physical dysfunction. Our
scientific contribution is expected to be significant because we are addressing a dire health comorbidity for
YpnHIV with deep clinical, imaging, functional and biomarker phenotyping in an endemic population. As a
consequence of the work proposed, we expect to uncover novel insights and a deeper understanding of the
pathobiology of contemporary HIV-related cardiovascular comorbidities.

Public health relevance
The proposed research is relevant to public health because determining whether children who acquire HIV perinatally have greater risk of cardiac dysfunction is expected to impact how we screen, treat and prevent heart disease in young people living with HIV. Of the 2.1 million children living with HIV worldwide, 1.8 million (roughly 88%) are in sub-Saharan Africa, thus, the goals of this project relate to those most heavily affected by the HIV epidemic. The project is relevant to the part of the NIH’s and NHLBI’s missions that pertain to addressing the impact of HIV-associated comorbidities including cardiovascular complications, the prevention of HIV-related heart failure, the epidemiology of HIV-associated comorbidities in sub- Saharan Africa and the risks for developing non-infectious cardiovascular comorbidities in perinatally HIV- infected individuals who have received long-term antiretroviral therapy.